Center for Advancing Multimorbidity Science: Profiling risk and symptom expression to develop customized therapies for adults with multiple chronic conditions (CAMS)

The overall goal of the Enrichment Program of the University of Iowa Center for Advancing Multimorbidity
Science is to provide continued and coordinated professional development and scientific enrichment for
Center Faculty, Affiliated Faculty, Associate Members, postdoctoral fellows and predoctoral students to
promote and improve the health of individuals with complex multiple chronic conditions. The Program will
enhance interdisciplinary biobehavioral research focused on adults with complex multiple chronic
conditions. Activities advance Center scientists' capacities to conduct research using NINR Common
Data Elements through continued and coordinated professional development and scientific enrichment
activities. The specific aims of the Enrichment Program are to:
1. Advance nursing science within the College of Nursing (CON) in profiling risk and customizing
therapies for adults with complex multiple chronic conditions; primarily through Developing
Scholars and Writing Groups, a CON Grants Workshop, a Lecture Training Series, and Visiting
Scholars program.
2. Across the University, support scientific exchange among investigators with research interests in
these topic areas, primarily through UI Clusters of Excellence, guest speakers at the Research
Forum, interactions with consultants, and the Center Research Seminar.
3. Facilitate interactions at the University and National level between Center scientists and
investigators from other fields with relevant expertise in profiling risk and customizing therapies;
primarily through Meet and Greet events within the University and attendance at Multimorbidity
and Symptom Science related topics held nationally at NINR, other NIH Institutes, CANS, and/or
the National Academy of Medicine (NAM).
The activities of the Enrichment Program are designed to advance the conduct of interdisciplinary
biobehavioral research that focuses on profiling risk and customizing therapies in MCC. These activities
will provide opportunities to build knowledge and skills to advance symptom science and Precision
Health through the conduct of pilot research, use of Common Data Elements, development of firm and
ongoing interdisciplinary research teams, enabled dissemination of products from pilot studies, and
formation of a foundation for more fully developed research projects.